Pre-Leukemic Hematopoietic Stem Cells in Human AML

PROJECT SUMMARY
Acute myeloid leukemia (AML) is an aggressive malignancy of the bone marrow affecting more than 20,000
adults annually in the United States. Even with aggressive chemotherapy and/or bone marrow transplantation,
five-year overall survival is between 30-40%. Genomic studies have demonstrated that most cases of AML are
associated with mutations in multiple genes, often occurring with a complex clonal architecture. Previous studies
demonstrated that these mutations are serially acquired in clones of self-renewing hematopoietic stem cells
(HSCs), identifying pre-leukemic HSCs (pHSCs) bearing pre-leukemic mutations. These pre-leukemic mutations
are enriched in genes involved in regulation of the epigenome, and the pre-leukemic cells acquire additional
mutations, often in genes involved in proliferation, leading to AML. Stratification of a cohort of AML patients into
high or low pHSC groups demonstrated that the high group had much worse overall and relapse-free survival,
indicating that the presence of pHSCs may be critical for clinical outcomes. A parallel line of genomic studies
investigated the presence of these AML-associated mutations in the blood of individuals with no history of
hematologic disease, a condition termed clonal hematopoiesis (CH). CH was found to be associated with an
increased risk of development of myeloid malignancy. Further whole genome sequencing studies used single
cell and computational methods to determine phylogenies of HSCs in individuals and to estimate time since initial
mutation and clonal expansion rates. These studies led to the conclusion that these pre-leukemic/CH mutations
can occur decades prior, even as far back as in utero, and that rates of clonal expansion can be predicted from
a single time point assessment, adding further complexity to the study of pre-leukemia and CH. These studies
provide novel and significant insights into the genetic events and cellular kinetics that occur in the development
of de novo AML. However, they also raise a number of new detailed questions with significant implications for
disease pathogenesis, prevention, and treatment. What is the duration of the pre-leukemic phase in individuals
that eventually progress to AML? Does this duration have any impact of disease pathogenesis? The pre-
leukemic HSCs give rise to a clone (clonal hematopoiesis) that produces cells of divergent phenotypes. What
are the characteristics and features of the pre-leukemic clone that eventually becomes transformed into AML
through the acquisition of additional mutations. As we noted in our prior studies, AML can develop in the
background of varying sized pre-leukemic clones, which is associated with patient outcomes. How does the size
or burden of the pre-leukemic clone impact the corresponding AML? Is this impact direct or indirect? This
proposal aims to investigate key questions related to pre-leukemic HSC clonal evolution, kinetics, and cell non-
autonomous effects based on the hypothesis that these features of the pre-leukemic phase and the pHSCs
themselves are critical contributors to AML pathogenesis. Ultimately, we postulate the pHSCs represent a critical
cellular target for the development of curative targeted therapies.

Public health relevance
PROJECT NARRATIVE AML develops through the stepwise accumulation of driver mutations in hematopoietic stem cells (HSCs) resulting in pre-leukemic HSCs that can also be found in aged normal individuals with a condition termed clonal hematopoiesis (CH). This proposal aims to investigate key questions of clonal evolution, kinetics, and cell non- autonomous effects and impact on the AML of the same patient based on the hypothesis that these features of the pre-leukemic phase and the pre-leukemic HSCs themselves are critical contributors to AML pathogenesis. Ultimately, we postulate the pre-leukemic HSCs represent a critical cellular target for the development of curative targeted therapies.